Dissecting multidrug resistance pathways in Trypanosomatids

PROJECT SUMMARY
Precisely how anti-trypanosomatid drugs kill parasites remains largely unknown. Trypanosomatid
infections, in the form of African trypanosomes, American trypanosomes, and Leishmania spp., directly
contribute to disease and poverty of over 1 billion people. Thus, gaps in knowledge have a significant human
impact. The well-established treatments nifurtimox, eflornithine, benznidazole, pentamidine, suramin, and
melarsoprol all suffer from complex treatment regimens, host toxicity, and burgeoning drug resistance. The high
host toxicity of melarsoprol (encephalopathy in ¼ of patents) made development of new drugs an imperative,
which has been answered by NECT (nifurtimox-eflornithine combination, intravenous) and fexinidazole (oral)
therapies. Despite this progress, mechanisms of cell death and drug resistance are unknown for fexinidazole
and other significant drugs. The ORFeome-based Trypanosoma brucei Gain-of-Function Library is the state-of-
the-art-tool for identification of both direct drug targets and mechanisms of drug resistance in trypanosomatids.
Discoveries from a published melarsoprol Gain-of-Function screen identified novel aspects of resistance
(including mitochondrial proteins). Unpublished data from a fexinidazole genetic screen demonstrated that drug
resistant survivors arise from induced expression of a clearly identifiable set of genes, which remain to be
elucidated. Multiple trypanocidal drugs converge on the same set of cytology phenotypes, suggesting shared
pathways to cell death. Based on genetic screening data and cytology-based phenotypes, this proposal will test
the central hypothesis that anti-trypanosomatid drugs share common mechanisms of cell killing and utilize
pathways that can promote multi- and pan-resistance against widely used therapies. In AIM 1, all clinically
relevant anti-trypanosomatid drugs (nifurtimox, eflornithine, benznidazole, pentamidine, suramin, and
fexinidazole) will undergo GoF genetic screening and validation to identify a set of genes that promote multi- and
pan-drug resistance. Multiple drugs converge on trypanosomatid redox and mitochondrial functions. AIM 2 will
use genetically encoded fluorescent biosensors to test the working hypothesis that anti-trypanosomatid drug
treatments perturb redox metabolism and ROS stress management in the cytosol and mitochondrion, filling a
gap in our understanding of drug-induced redox stress. Drug cytotoxicity in T. brucei is associated with a set of
established phenotypes, AIM 3 will determine how multi-resistance genes contribute to cell death phenotypes
including: cell cycle, DNA damage, and loss of mitochondrial functions. The proposed research is of high
significance because it will link trypanocidal phenotypes with their associated genes and genetic pathways for
the first time. Genes whose expression promotes multidrug resistance will elucidate the pathways that lead to
cell death in these parasites. Discoveries arising from these studies will illuminate mechanisms of cell death for
all existing trypanosomatid therapies and identify targets for improved drug design. This proposal will enable
better informed choices in anti-parasitic compound development and screening for years to come.

Public health relevance
PROJECT NARRATIVE Drug therapy is required to treat trypanosomatid parasite infections, yet existing drugs suffer from challenging treatment regimens, emerging drug resistance, and significant gaps in our understanding of their mechanisms of action and trypanocidal targets. The proposed research will use a state-of-the-art genetic screening tool to identify genes whose expression promotes resistance against the clinically relevant anti-trypanosomatid drugs currently in use. The phenotypes imparted by multi-resistance genes will then be evaluated to identify pathways that result in drug resistance and, conversely, cell death, the outcomes of which will be transformative for future drug development in trypanosomatid parasites.